Clinical Research Core

PROJECT SUMMARY
The Clinical Research Core (RC1) is a key resource for the University of Florida (UF) Older Americans
Independence Center (OAIC), providing the resources and expertise for conducting research across the
spectrum of clinical investigation, including clinical trials, as well as observational studies of biological and
behavioral factors related to promotion of mobility and independence. The Core’s primary goal is to
encourage and facilitate clinical translational research focused on promotion of mobility and independence.
The RC1 has three Specific Aims:
1. Aim 1: Provide the resources and intellectual environment to facilitate clinical research, team science,
and education of OAIC REC Scholars, including under-represented investigators, related to promotion
of mobility and independence.
2. Aim 2: Promote and facilitate translation of pre-clinical and pilot studies into clinical trials in older
persons with consideration for sex and ethnicity/race.
3. Aim 3: Improve our understanding of behavioral, biological, cognitive, and social/environmental factors,
with a focus on health disparities, that may affect responses to interventions, designed to promote
mobility and independence in older adults.
The RC1 provides resources and personnel (including U01 and R01 NIH funded investigators) to support the
development and implementation of clinical trials, including pharmacologic, nutritional and behavioral
interventions, and observational studies addressing factors contributing to mobility impairment in older adults
and implications for functional decline and disability. Building on close collaborations with other OAIC cores,
the RC1 will support pilot/exploratory projects, developmental projects, and external projects. The Core will
also provide senior level Investigators with established track records as mentors for research education to lead
each of these goals, providing expertise and promoting a rich environment for early stage faculty research and
senior faculty collaboration.